GUANFACINE TREATMENT OF TOURETTE'S SYNDROME AND ADHD

Guanfacine (Tenex) safety and efficacy is being assessed in the treatment of Tourette's Syndrome (TS) and Attention Deficit Hyperactivity Disorder (ADHD) occurring separately or as comorbid conditions.